BrainStorm: Highly Extensible Software for Advanced Electrophysiology and MEG/EEG Imaging

PROJECT SUMMARY / ABSTRACT
Brainstorm is a Matlab/Java multi-platform (Linux, MacOS, Windows) software environment for analysis and
visualization of electrophysiological (e-phys) data. While originally focused on noninvasive EEG and MEG,
Brainstorm now also includes tools for analysis and advanced visualization of a broader range of data modalities:
intracranial EEG including ECOG, SEEG macroelectrode recordings, MUA and LFP microelectrode data in
humans and in-vitro/in-vivo preparations in animal models, and noninvasive NIRS data. The software is widely
used and plays an increasingly important role in clinical and cognitive neuroscience research as reflected in the
following statistics over the past decade: 1,700 published articles reporting analyses performed with Brainstorm,
30,000 user accounts, 34,000 posts on the online user forum, and 2,000 students, postdocs and faculty around
the globe have attended in-person or online Brainstorm training events. Over the past four years we have built
on the extensive capabilities of Brainstorm by defining and implementing a BIDS-compatible database structure
and adding tools for cloud/advanced computing over distributed data resources. We have added improved
interfaces with other EEG/MEG software, leading spike-sorting e-phys software, and hardware (including the
ability to import from multiple commercial file data formats). We have also added interoperability with MRI-
analysis software and deployed tools for FEM-based head modeling. Under this renewal we will address the
following: Aim 1: Enabling Tools for Naturalistic and Single-Trial Neurophysiology Studies: There is
increasing scientific interest in eliciting, recording, and analyzing neural responses to non-repetitive and
naturalistic stimuli. Data of this type present particular challenges in terms of documenting rigorously varied,
uncontrolled sensory events and behavioral responses with machine and human readable annotations, and
relating such complex sensory presentations and behavior to measured brain activity. We will therefore develop
a suite of tools for preparing and analyzing multimodal e-phys data in the context of naturalistic neuroscience.
Aim2: Tools for Invasive Recordings: We will build on developments in the current project period to provide
tools for preprocessing and analysis of invasive recordings and FEM-based modeling of intracranial current fields
including labelling, localization and co-registration of complex iEEG electrode montages from X-ray CT to MRI,
automated identification and tagging of interictal features in iEEG, and characterization, localization and
validation of neuronal sources from iEEG. Aim 3: Software Enhancement, Integration, Maintenance,
Training, and Documentation: We will pursue a three-pronged development track: (i) a hub-based framework
in which third-party tools can be linked, run and with results visualized entirely from Brainstorm as a hub; (ii) build
on our existing provenance tools so that users can save analysis histories to allow full reproducibility; and (iii)
provide links and interoperability with statistical packages to promote rigor. We will continue to develop
Brainstorm with multiplatform compatibility, web-based documentation, user forums, and hands-on training.

Public health relevance
Project Narrative Magnetoencephalography (MEG) and Electroencephalography (EEG) are non-invasive brain imaging tools for studying normal human cognition as well as neurological and psychiatric illnesses, including epilepsy, schizophrenia, obsessive-compulsive disorder, autism spectrum disorders, and Alzheimer’s disease. The neuroscience research community has an ongoing need for validated and documented open-source software to perform analysis and to facilitate reproducible and large-scale research involving electrophysiological data. This project continues to develop and support Brainstorm, open-source software that meets these needs with well-documented and tested novel analyses using MEG and EEG in combination with anatomical MRI and intracranial EEG data.